Detection of novel environmental risk factors in the recently identified ALS clusters in Central Virginia

ABSTRACT
Amyotrophic lateral sclerosis (ALS) is a rare, neurodegenerative condition that results in rapidly progressive
muscle weakness and, ultimately, death from respiratory failure within 2-5 years of symptoms onset. The VCU
Department of Neurology runs the largest ALS clinic in the region and, over the past 4 years, began witnessing
an uptick in incident ALS cases. In partnership with the ALS Association, we analyzed the spatial distribution of
ALS in Virginia. We identified apparent spatial ALS clustering with the highest relative risk of 3.75 for
developing ALS in these “hotspots.” It should be mentioned that ALS has a global incidence of 2 per 100,000.
There is mounting evidence that ALS stems from a combination of genetic susceptibility, age-related cellular
damage, and environmental exposure. We, therefore, investigated whether local environmental factors
contributed to increased ALS risk in these “hotspots.” Analysis of drinking water samples from households of
ALS patients from this cluster identified elevated levels of a plasticizer dtBHQ (2,5-ditert-butylhydroquinone). At
this point, it is unknown how dtBHQ appears in drinking water in these regions, but a reported application of
dtBHQ is in the coatings of water pipes. Nonetheless, the presence of dtBHQ is intriguing, given some reports
that at high doses, dtBHQ can cause muscle weakness and damage motor endplates in rats. Next, we
investigated whether low-level exposure to dtBHQ could cause motor impairment in laboratory animals. Using
a Zebrafish model system, we found that dtBHQ at nanomolar concentrations decreased touch-evoked
response and caused shortening of primary motor axons and reduced branching indicative of motor circuit
dysfunction. These preliminary results led us to propose a central hypothesis that the presence of a plasticizer
dtBHQ in the environment of ALS clusters activates molecular mechanisms that cause motor neuron toxicity,
contributing to the elevated risk of ALS in these hotspots. We are applying under Funding Option B and our
proposal meets both of the RFA-TS-25-036 funding objectives by identifying a potential environmental risk
factor for ALS and investigating how this risk factor contributes to the pathophysiology of ALS. Thus, for this
investigation, in Aim 1, we will investigate the environmental and occupational risk factors in our ALS clusters
through deep qualitative interviews. We will also compare this data with the National ALS Registry
Epidemiological data of registrants from Central Virginia and the National cohort. In Aim 2, we will collect water
specimens from households in ALS clusters and analyze them for dtBHQ levels and the presence of other
toxicants. In Aim 3, we will investigate whether sustained, low-level exposure to dtBHQ activates neurotoxic
pathways that cause motor neuron toxicity and lead to the expression of ALS-like phenotype using zebrafish
and mice as model systems. This study will provide new data on the presence of a novel environmental
toxicant and its role in elevating the risk of ALS in humans.

Public health relevance
PROJECT NARRATIVE This project will conduct a deep qualitative study to identify environmental risk factors for ALS in newly identified “ALS hotspots” in Central Virginia. Water specimens from households of ALS patients will be analyzed to detect toxicants and contaminants, and exposure modeling of identified toxicants in laboratory vertebrate animals will be conducted to study the effect on neuromuscular function and identify mechanisms of toxicity. Our studies will reveal novel risk factors for ALS and deepen our understanding of how environmental toxins affect ALS outcomes.